Harnessing Redox Regulation of Proteasome Function to Promote Healthy Aging

PROJECT SUMMARY
For half a century, groups across the world have been investigating the hypothesis that reactive oxygen
species influence the biology of aging. However, technical limitations have, until recently, heavily limited the
precision at which studies can interrogate this hypothesis. For example, reactive oxygen species are
known to post-translationally modify cysteine residues on proteins throughout the proteome, however,
only recently have proteomic techniques been developed allowing for deep and quantitative analysis of
cysteine oxidation on proteins in a biological sample. This proposal will develop preliminary data which
identified a broad increase in cysteine oxidation across 10,970 cysteines in the proteome in C. elegans during
aging and begin to link these events to regulation of the biology of aging. Specifically, this proposal will
focus on redox regulation of proteasome activity during aging. First, this proposal will determine the relative
contribution of cysteine oxidation to regulating age-dependent changes to proteasome activity. Second, this
proposal will identify and define regulatory cysteines involved in redox regulation of the proteasome and
determine their influence in the maintenance of longevity. Third, this proposal will generate new cysteine
oxidation data sets to determine how longevity interventions influence the trajectory of age-dependent
cysteine oxidation. Finally, this proposal will evaluate the intriguing hypothesis that reactive oxygen
species can be carefully titrated to promote fitness through stimulating dormant proteasome activity in
aged organisms. This work will synergistically employ the skillsets of multiple investigators to perform
impactful, cutting-edge research. In addition to providing significant insights into important areas of cell
biology, the proposed work will also contribute to the development of a future academic scientist at Harvard’s
T.H. Chan School of Public Health, one of the best places to receive scientific training in the world. These
studies will both develop a research program which the trainee can use to establish an independent, academic
scientific research group as well as equip the trainee with the skillset needed to be successful in this
professional domain. The trainee will receive experience in all areas required of a successful academic
investigator, such as mentoring, scientific communication, grant writing, project management and
budgeting and receive significant technical training in a new model system, new fields and many new
techniques. Together, this work will define fundamental mechanisms contributing to development of the
biology of aging with broad implications for human health and disease and provide strategies to promote
healthy aging.

Public health relevance
PROJECT NARRATIVE An increase in the concentration of reactive oxygen species has been thought to be a mechanism promoting development of the biology of aging for over half a century, however, technical limitations have until recently substantially limited investigation of this hypothesis. This proposal will develop preliminary findings that identified specific targets of reactive oxygen species which influence aging phenotypes through post-translational regulation of proteins by cysteine oxidation. Upon completion, this study will establish mechanism(s) and produce resources outlining how reactive oxygen species influence the biology of aging which can leveraged to develop new strategies to promote healthy aging.